MUSC Digestive Disease Research Core Center

Center Overview - Abstract
The vision for the Medical University of South Carolina (MUSC) Digestive Disease Research Core Center
(DDRCC) is to create a culture of curiosity, scholarship, and investigation around our central theme. Our theme
is informed by the pathogenesis of disease in the gastrointestinal tract, from cellular injury, inflammation, fibrosis,
and ultimately end organ dysfunction and disease. Our specific emphasis on human disease is part of our
rationale for the extension of the continuum of our theme - from injury to disease. Further, we expect the work
by Center members to lead to new treatments for patients with gastrointestinal disease.
Our specific aims are integrated with the specific goal to serve our Research Base/Full Members and our mission;
specific aims are as follows: (1) First, we will foster collaboration among digestive and liver disease
researchers. We will leverage collaborations among MUSC investigators to further augment our research
capacity while ensuring the success of a critical mass of outstanding researchers in digestive and liver diseases.
This will be supported through multiple synergistic efforts as described in the Administrative Core including
DDRCC leadership and Enrichment and Pilot and Feasibility Programs. (2) We will develop sustainable
scientific core resources that will specifically support digestive and liver disease studies while
leveraging institutional investments. The DDRCC scientific cores include: a) Analytical Cell Models Core,
which will deliver high quality, pure primary liver cells and produce state-of-the-art tissue culture models; b)
Advanced Imaging Core with advanced cell- and tissue-based imaging techniques and instrumentation; and c)
Proteomics Core with innovative mass spectrometry imaging capabilities. These cores are complemented by a
committed Clinical Component which provides support for the design, implementation and analysis of research
studies to improve clinical outcomes for patients with digestive diseases. Finally, we will (3) Promote the long-
term success and sustainability of the DDRCC through dedicated mentorship of New Investigators, a rigorous
Center evaluation and process improvement strategy, mission alignment with other centers at MUSC, and
specific long-term institutional commitments to the Center.
The MUSC DDRCC is made up of 29 Full Members focused specifically on our theme, and who constitute our
Research Base of $10.8M. We also have 31 Associate Members who are active participants in the Center. The
DDRCC has enormous potential to answer important questions, open new areas for further inquiry, and result in
potential new therapeutic discoveries that will be translated to new treatments for patients with digestive and
liver disease.

Public health relevance
Center Overview - Project Narrative Gastrointestinal diseases place a tremendous burden on US and South Carolina healthcare. The vision for the Medical University of South Carolina (MUSC) Digestive Disease Research Core Center (DDRCC) is to improve gastrointestinal health by providing support for existing digestive and liver disease research at MUSC via development of new opportunities for collaboration and research programs. The MUSC DDRCC Biomedical Research Cores (Analytical Cell Models, Advanced Imaging, and Proteomics), Clinical Component, and Pilot & Feasibility and Enrichment Programs will create a multifaceted foundation that will support this mission.